Developmental Therapeutics (DT)

PROJECT SUMMARY/ABSTRACT (DEVELOPMENTAL THERAPEUTICS)
Members of the Developmental Therapeutics (DT) Program use breakthrough insights made at the Rogel Cancer
Center basic science programs to discover small molecule anticancer agents that can be advanced into
biomarker-driven clinical trials. The Program serves as the forum for investigators with shared interest in
identification and validation of new cancer-relevant targets and development of novel anti-cancer agents that
perturb epigenetic modifiers, block protein-protein interactions, inhibit kinase activities or induce degradation of
cancer-relevant protein targets. The DT Program comprises 31 members from 14 departments across four
schools and colleges at the University of Michigan. Total annual direct research support is $14.3M, with $6.2M
(43%) from the NCI, $2.9M (21%) from other NIH support and $0.8M (5%) from other peer-reviewed sources.
During the last funding period, and in close collaboration with the Structure and Drug Screening as well as
Pharmacokinetics Shared Resources, DT Program members authored 552 publications, of which 16.5% are
intra-programmatic and 32.8% are inter-programmatic. To further these advances, DT Program research is
focused on one or more of the following Specific Aims: 1) validate novel cancer targets that are amenable to
pharmacologic intervention, 2) discover, optimize and evaluate promising therapeutic agents and potential
biomarkers of response in clinically relevant preclinical model systems, and 3) advance DT drug candidates into
clinical trials through structured collaborations with clinical investigator teams. The overarching goal of program
members is to generate critical preclinical proof-of-concept data for promising new cancer therapies in a manner
that will serve to guide clinical trial design and maximize translational impact.